Ferroptosis in the Heart: Iron Calcium Crosstalk and Compartmentalization

Summary
Approximately one person dies from heart disease every 30 seconds in the United States. About 1.5 million
Americans die from myocardial infarction each year. Clinically, genetic disorders (e.g. hereditary
hemochromatosis) and repeated blood transfusions (as required for sickle cell anemia and beta thalassemia)
are known to cause Fe accumulation in the heart with iron overload cardiomyopathy being a major cause of
death. It has been recently reported that dilated cardiomyopathy occurs in up to 95% of patients with
Duchenne muscular dystrophy and that iron levels are elevated in mouse models. Furthermore, iron levels are
known to be elevated in the heart after ischemia followed by reperfusion. Nevertheless, the underlying
mechanism(s) involved in Fe associated cardiotoxicity remain unclear. Calcium and iron are both known to
play vital cellular roles in the heart. Cells exhibit a remarkable dependence on keen regulation of calcium and
iron concentrations. Cellular dysregulation of either ion can result in systolic and diastolic dysfunction and
ultimately cardiomyopathy. Loss or disruption of normal homeostasis of cellular calcium and/or cellular iron
concentrations can not only cause direct myocardial cardiotoxicity, but can also result in loss of myocardial
excitability and abnormal excitation contraction coupling. We propose that a cross talk between calcium and
iron combined results in a highly cardiotoxic cellular environment. We posit that the presence of iron can result
in cell death via an underappreciated pathway, i.e. ferroptosis in the heart resulting in cardiomyopathy as well
as ischemia reperfusion injury. Furthermore, we propose a similar link between myocardial stunning seen after
brief periods of ischemia reperfusion to be in part due to the same cross talk resulting in a partially reversible
reduction in myocardial systolic function. Linking the transport of calcium and iron signaling is the mitochondria
Ca uniporter (mCU) and the activation of transient receptor potential canonical channels. We show that iron
can regulate TRPC ion channel function. Our preliminary data have shown that TRPC channels are directly
activated by iron. Importantly, activation of TRPCs has been implicated in calcium paradox injury and post-
myocardial infarction remodeling. We aim to demonstrate that neither calcium nor iron are simply passive
participants in cellular processes, but when forces are joined result in systolic and diastolic failure of the heart,
cardiotoxcity, and together are predictive of a reduced lifespan in humans. We will demonstrate that it is
cellular diastolic calcium and mitochondrial calcium that defines cell death and myocardial function with iron
loading. We hypothesize that mCU accounts for mitochondrial iron overload and that an interaction (or
crosstalk) between elevated diastolic calcium and increased mitochondrial iron results in a highly volatile and
cardiotoxic environment that causes cardiac cell death via ferroptosis resulting in cardiomyopathy and
ischemia reperfusion injury. The field of ferroptosis is nascent in many regards when it comes to the heart.
The key drivers and pathways of ferroptosis in the heart differ depending on biological context. In summary,
there is a wealth of foreseeable opportunities to elucidate both the trigger(s) and pathways activated that can
result in ferroptosis and its role in various forms of cardiac cardiomyopathy and ischemia-reperfusion injury.
Our preliminary studies have demonstrated ferroptosis in iron induced cardiomyopathy and Duchenne
Muscular Dystrophy cardiomyopathy. We will use woodchucks that have been shown by us to be protected
from ischemia reperfusion injury as a tool to identify novel anti-ferroptosis pathways that can be targeted for
treatment and/or preventative therapies. We will pursue the following aims. Aim 1: Determine the role of
mCU and TRPCs in Fe induced cardiac dysfunction at the level of the isolated myocyte and in vivo.
Sub-aim 1-1: We will demonstrate in vitro and in vivo whether mCU mediated Fe uptake and Ca dysregulation
are associated with Fe induced cardiac toxicity. We will confirm mito Fe loading is mediated by mCU. The
effects of Fe treatment on mito function, oxidative stress and the role of mCU will be defined. Sub-aim 1-2: We
will demonstrate Fe induced activation of TRPCs and the relationship to cardiac dysfunction in vitro (acute) and
in vivo (Fe-CM). Sub-aim 1-3: Data derived from Sub-aims 1-1 and 1-2 will be used to populate a computer
model of E-C-M coupling and simulations run with incorporation of Fe effects. Aim 2: To determine pathways
involved in ferroptosis in Fe-CM, DMD-CM, and Woodchucks during I/R injury. Sub-aim 2-1: We will
determine whether mito Fe uptake via mCU plays a role in ferroptosis with Fe loading and test other known
inducers of ferroptosis. We will determine the role of ROS and TRPC in vitro and in vivo with Fe loading and
I/R. Sub-aim 2-2: In DMD-CM hearts, we will determine remodeling of ferroptosis-related genes and proteins,
evaluate biomarkers, and test the susceptibility to ferroptosis inducers in vitro. We will test various ferroptosis
pathways and attempt to mitigate DMD-CM by inhibiting ferroptosis in vivo. Sub-aim 2-3: We will obtain novel
insights into protective mechanism(s) in woodchucks during I/R (in vitro and in vivo).

Public health relevance
Narrative Although calcium (Ca) and iron (Fe) are known to play vital cellular roles in the heart, when there is dysregulation of these two ions there are different pathways that can result in myocardial damage and systolic failure. Under specific biological pathologies, multiple signaling pathways can dictate the susceptibility of cardiomyocytes to contractile failure. We propose that it is an active cross talk and cellular signaling between dysregulation of both Fe and Ca that leads to myocardial contractile failure, ischemia reperfusion injury and ultimately cardiomyopathy (CM). We will identify triggers and signaling pathways that are involved in the observed systolic and diastolic dysfunction and ferroptosis associated with iron induced CM and Duchenne muscular dystrophy associated CM. We will also create an E-C Mitochondria (ECM) coupling 3D network model based on our experimental findings to be used in an interpretative as well as predictive fashion. Our project will therefore address broad scientific as well as clinical questions with regard to the mechanism of clinical myocardial stunning, I/R injury, and CM.